Targeting Novel Fibrogenic Signaling Pathways to Prevent Injury and Age-Related External Anal Sphincter Muscle Dysfunction

Women Veterans are the fastest-growing population and pelvic floor disorders such as anal/fecal incontinence
(FI) are highly prevalent in women. Fecal incontinence (accidental leakage of stools; FI) that occurs in a
significant population of women (>7%), is attributed to childbirth-related injury to the external anal sphincter (EAS)
and pelvic floor muscles, by a variety of mechanisms, i.e., stretch, ischemia, spontaneous avulsions and surgical
incision (episiotomy). Many FI patients develop symptoms after about 5 decades of life and the risk increases
with advancing age, the reasons for which are not clear. In addition, these patients show anatomical disruptions
and impairment of EAS muscle function. Our animal (rabbit) studies confirm these findings and further
demonstrate abnormal healing with increased fibrosis and disorganized fiber orientation in the regenerating
muscle after experimental EAS myotomy. Similar charges were also seen in old animals. Our mechanistic studies
show upregulation of fibrosis network involving Wnt-β catenin/ STAT3 proteins and a novel central hub for multi-
receptor driven profibrogenic signaling, GIV/Girdin in the injured as well as old animals. We hypothesize that
impaired muscle regeneration/fibrosis after EAS injury as well as increased muscle atrophy observed during
advanced aging is mediated by common molecular pathways involving Wnt-Frizzled, β-Catenin/TCF/LEF, STAT-
3 and GIV/Girdin signaling proteins. A clear understanding of these molecular mechanisms involved in sphincter
fibrosis/atrophy would enable the identification of a novel target for the development of innovative strategies to
prevent/ treat this disorder. The specific aims of our studies are to determine: 1. Mechanisms of injury-related
sphincter muscle dysfunction; 2. Mechanisms of age-related sphincter muscle dysfunction, and 3. Mechanisms
of the cumulative impact of age on injury-related sphincter muscle function. We will use a rabbit model and several
novel approaches, 1; longitudinal measurement of in-vivo length tension function of the EAS muscle in animals,
2; use of Wnt antagonists (sFRP2), small molecule inhibitors (STAT3) and gene silencing (Girdin siRNA)
approach to modulate fibrogenic signaling networks with an ultimate goal of improving sphincter function in our
studies. Mechanistic insights gained from these studies will not only examine the topic from the molecular level
to the level of whole animals but also unravel novel targets for further development of treatment strategies to
prevent muscle fibrosis both in the setting of post-injury and aging-related incontinence. Thus, our proposal is
both conceptually novel (studies a novel fibrogenic signaling network), and innovative (uses novel approaches
and interventions to study sphincter and improve sphincter function), paving the way for new treatment strategies
Successful conclusion of this study has a high potential for clinical translation (development of anti-fibrotic
interventions) to maximize functional recovery (anal continence function) in the post-partum and aging population.

Public health relevance
Anal /fecal continence (FI) is a major medical illness, as it affects many Veterans, and it affects their quality of life. Many FI patients develop symptoms after about 5 decades of life and the risk increases with advancing age, the reasons for which are not clear. Currently, there are no effective preventive strategies. The major focus of this proposal is to understand and evaluate pathophysiological changes. These studies will also evaluate the application of a novel multimodal intervention approach to prevent FI in an animal model. We believe the proposed studies will have important therapeutic implications for the treatment strategies for FI.